Functional architecture of striatal networks in cue-reward learning

Project Summary
The mesocorticostriatal network is central to adaptive reward processes, as well as diseases of
dysfunctional learning, motivation, and cognition. As learning progresses, there is a transition from initial
reliance on nucleus accumbens (NAC) to later recruitment of dorsolateral striatum (DLS), which drives a shift
from goal-directed behavior to more automatic behaviors characterized by rapid, stimulus-driven movement
sequences. This transition is thought to involve a network of recurrent loops, including dense dopaminergic
(DA) input from the ventral tegmental area (VTA)/substantia nigra (SNC) and glutamatergic input from cortex.
Critically, however, the contributions of these loops have not been directly tested, and the circuit mechanisms
driving this fundamental neurobiological adaptation remain undefined. In the proposed studies, we will use
several innovative approaches to investigate how different loop systems within the mesocorticostriatal network
communicate in vivo to organize conditioned behavior, and transition from ventral to dorsal striatal control,
across learning. One influential anatomical framework, the mesostriatal “spiral” hypothesis, suggests that
during learning, information flows serially across a subcortical loop, from the VTA to nucleus accumbens to
SNC, to dorsolateral striatum. Despite broad acceptance in the field, support for the striatal spiral has not been
demonstrated in vivo. Instead, emerging evidence suggests an alternative hypothesis: that cue-reward learning
engages progressive recruitment of the dorsal striatum via nigro-thalamo-cortical circuits, rather than the
classic striatal spiral mechanism. In Aim 1 we will combine fiber photometry recordings of somatic DA neuron
activity in TH-cre rats with simultaneous recordings of a DA biosensor in the striatum, to characterize the
spatial and temporal pattern of information flow through four nodes in the striatal DA system during cue-reward
(i.e., Pavlovian) learning, testing predictions from the spiral framework. In Aim 2, we will use trans-synaptic
targeting, optogenetics, and photometry to test the ascending spiral framework in vivo, determining if NAC
direct pathway neurons disinhibit SNC DA neurons. We will use D1-cre rats to investigate the function of direct
pathway output neurons in the NAC and DLS at different stages of learning. Finally, In Aim 3 we will combine
photometry recordings of corticostriatal and thalamostriatal circuits with optogenetic manipulation of DA
neurons in TH-cre rats, to assess the ability of nucleus accumbens DA signaling to engage the nigro-thalamo-
cortical loop. We will then optogenetically manipulate input-defined nigral neurons projecting to the thalamus to
determine the functional role of the nigro-thalamo-cortical loop in learning. These studies will resolve
longstanding questions about the circuit mechanisms of information flow across striatal input-output circuits,
establishing a normative framework for the in vivo functional architecture of the mesocorticostriatal network.

Public health relevance
Project Narrative Fundamental behaviors, including reward-based learning, attention, and movement invigoration, rely on a complex recurrent network of striatal, midbrain, thalamic, and cortical brain circuit loops. Here, we propose to functionally dissect the anatomical organization of this system, using new methods to simultaneously manipulate and measure neural activity in multiple circuits at once during behavior. Our goal is to better understand information flow at the network level, for insight into basic neurobiological mechanisms of normal and pathological states.